The Unfolded Protein Response in Murine and Pediatric Cholestatic Liver Diseases

Cholestatic liver diseases, including biliary atresia (BA), are the leading indication for pediatric liver transplant
and there are no effective medical therapies for patients that decrease the need for transplantation. This is due,
in part, to the lack of understanding of how the liver reacts to bile acid induced injury in children, including the
hepatocyte activation of the unfolded protein response (UPR). The UPR is a protective molecular response that
decreases endoplasmic reticulum (ER) stress which can occur in the setting of cholestasis, in part through
induction of ER-associated degradation (ERAD) pathways. Our laboratory’s previously published and present
preliminary data using several models of ER stress demonstrate that young mice have inadequate UPR
activation (specifically within the XBP1 pathway) compared to adult mice, and this is associated with increased
liver injury. The same pattern of impaired XBP1 pathway activation occurs in explanted livers from pediatric
patients with cholestatic liver diseases compared to both normal and disease controls. The goal of my current
investigations is to increase the understanding of the pathophysiologic hepatic responses of the XBP1 pathway
to cholestatic liver injury and identify changes during postnatal development that influence UPR activation. This
will allow us to target specific UPR pathways for the development of novel treatments for pediatric cholestatic
liver diseases. Therefore, I have formulated the following Specific Aims: 1) To define age-dependent changes
in XBP1 transcription factor function using murine models of ER stress 2) To define the protective
mechanism of XBP1 regulation of ERAD in chronic cholestasis and 3) To determine the changes in
mechanism of XBP1 signaling which occur in murine and human biliary atresia (BA). Using murine models
of ER stress and cholestasis and human liver tissue from BA patients we will identify the mechanism of XBP1
specific pathway changes that occur during post-natal development, and how these changes influence disease
progression in response to cholestasis-induced ER stress. Candidate and Career Development: I am a
pediatric hepatologist at Northwestern University who has a demonstrated commitment to basic/translational
research throughout my early career. My long-term career goal is to become an independent, extramurally
funded physician-scientist with a focus on the hepatocellular UPR response in pediatric cholestatic liver
diseases. This K08 proposal will help achieve this goal by advancing my scientific skills and knowledge in gene
regulation, cellular signaling pathway analysis and high-throughput data analysis, as well as defining the role of
the unfolded protein response in murine cholestatic liver disease models and correlative human diseases. Along
with my co-mentors, Drs. Green and Barish, I have developed a career development plan to achieve these goals
through didactic lectures, mentoring, and hands-on laboratory training. This proposal will provide the protected
time and research training for future R01-level proposals extending mechanistic XBP1 pathway studies within
pediatric cholestatic liver diseases and investigating UPR-related therapeutics.

Public health relevance
PROJECT NARRATIVE: Cholestatic liver diseases, including biliary atresia, are the leading indication for pediatric liver transplantation. Evidence suggests that the unfolded protein response (UPR) is important in the progression of several adult liver diseases, yet the UPR is understudied in pediatric cholestatic liver diseases. We aim to define the role of the liver XBP1 pathway of the UPR postnatally and in models of cholestatic liver diseases in mice and human patients with biliary atresia in order to develop UPR specific therapeutic interventions for pediatric patients with cholestatic liver diseases.